Beta-cell Compensation In Partial Pancreatectomy Mice

DESCRIPTION (provided by applicant): The islet [unreadable]-cell is the key regulatory element of the glucose homeostasis system. Changes in insulin sensitivity and/or [unreadable]-cell mass elicit precise adaptations from the remaining [unreadable]-cells so normoglycemia is maintained. How is that accomplished? What signaling pathways and [unreadable]-cell molecular processes are involved? This application continues our studies of the [unreadable]-cell adaptive mechanisms to a reduction in [unreadable]-cell mass such as occurs in evolving type 1 diabetes, likely also type 2 diabetes, using the experimental model of 60% pancreatectomy (Px) in normally insulin sensitive rodents. These rodents are normoglycemic following the reduction in [unreadable]-cell mass because of a multifacted adaptive response in islet [unreadable]-cells that results in maintenance of a normal level of secreted insulin. We plan to test a well-defined mechanistic schema for the adaptive responses based on findings from the prior funding period. Specifically, we propose an essential role for PPARγ by way of its transcriptional regulation of key genes that impact [unreadable]-cell function and survival (pdx-1), the incretin system (GIP receptor), and mitochondrial fuel metabolism (pyruvate carboxylase). Also, we propose upstream transcriptional regulation of PPARγ by the forkhead transcription factor FoxO1. Finally, we propose disruption of this signaling system is responsible for features of the [unreadable]-cell dysfunction in animals and humans with type 2 diabetes. We will test these hypotheses in mice with genetically altered expression of key elements in the proposed signaling pathways - pancreas specific PPARγ knockout, whole animal heterozygous FoxO1, and constitutively nuclear FoxO1 in [unreadable]-cells and liver - that undergo 60% Px or treatment with pharmacologic activators of the proposed signaling pathway. Parallel in vitro studies will be performed in mouse and human islets and INS-1 cells. Aim #1 will test the hypothesis of a necessary role for PPARγ in the enhanced [unreadable]-cell function post-Px using pancreas-specific PPARγ null mice, and confirm PPARγ regulates the same target genes in human islets. Aim #2 will define the molecular interaction between FoxO1 and PPARγ in vitro, confirm the same regulation occurs in human islets, and compare expression of PPARγ-regulated genes and [unreadable]-cell function following Akt activators (GLP-1 and insulin) and 60% Px in wild type and mutated FoxO1 mice. Aim #3 will use in vitro and in vivo studies to confirm that hyperglycemia impairs [unreadable]-cell PPARγ signaling and consequently expression of its downstream regulated genes, and investigate strategies to restore PPARγ expression in order to improve hyperglycemia-induced [unreadable]-cell dysfunction. PUBLIC HEALTH RELEVANCE: The islet [unreadable]-cell regulates the storage and metabolism of cellular fuels through its secretion of insulin. Not surprisingly, the regulatory systems governing insulin secretion and biosynthesis, and the [unreadable]-cell mass, are complex. The best-studied factor is glucose;in reality, the primary action of [unreadable]-cells is to maintain the normal metabolic milieu. When functioning normally, an altered insulin sensitivity or [unreadable]-cell mass is balanced by precise compensatory changes in insulin secretion (so called [unreadable]-cell adaptation) so glucose homeostasis is maintained. Thus, the normal system of glucose homeostasis is based on [unreadable]-cell adaptive mechanisms that entail molecular and signaling processes that are not dependent on sustained changes in glycemia. Surprisingly little is known about this fundamental feature of how [unreadable]-cells function. The overall goal of our studies is to identify the [unreadable]-cell biochemical, molecular and functional events that underlie this adaptation. Our laboratory has taken the approach of studying rodents with successful [unreadable]-cell adaptation to a lowered [unreadable]-cell mass or insulin resistance as defined by normoglycemia. This application continues our studies of the [unreadable]-cell adaptive mechanisms to a reduction in [unreadable]-cell mass as occurs in evolving type 1 diabetes, also likely type 2 diabetes, using the experimental model of 60% pancreatectomy (Px). We now propose to test a well-defined mechanistic schema based on our findings from the prior funding period, by performing Px studies in mice with genetically altered expression of key elements of the proposed regulatory pathway. Specifically, we propose an essential role for hyperexpression of [unreadable]-cell PPARγ to upregulate transcription of key genes for [unreadable]-cell function and survival (pdx-1), the incretin system (GIP receptor), and mitochondrial fuel metabolism (pyruvate carboxylase). Also, we propose deactivation of the FoxO1 inhibitory upstream regulation of PPARγ transcription is the mechanism for the PPARγ hyperexpression. Finally, we pro- pose that disruption of this signaling system is responsible for features of the [unreadable]-cell dysfunction in animal and human type 2 diabetes. We will test these hypotheses in mice with genetically altered expression of key elements in the proposed signaling pathways - pancreas specific PPARγ knockout, whole animal hetero- zygous FoxO1, and constitutively nuclear FoxO1 in [unreadable]-cells and liver - that undergo 60% Px or treatment with pharmacologic activators of the proposed signaling pathway. Parallel in vitro studies will be performed in mouse and human islets and INS-1 cells. A notable feature is the interdisciplinary nature of the studies because of the complimentary expertise of the principal investigator Jack Leahy ([unreadable]-cell biochemistry, physiology, in vivo animal models) with Tom Jetton (imaging techniques to study islet cell biology) and Mina Peshavaria (molecular and cellular biology of the [unreadable]-cell) at the University of Vermont.

Public health relevance
PROJECT NARRATIVE The islet ss-cell regulates the storage and metabolism of cellular fuels through its secretion of insulin. Not surprisingly, the regulatory systems governing insulin secretion and biosynthesis, and the ss-cell mass, are complex. The best-studied factor is glucose; in reality, the primary action of ss-cells is to maintain the normal metabolic milieu. When functioning normally, an altered insulin sensitivity or ss-cell mass is balanced by precise compensatory changes in insulin secretion (so called ss-cell adaptation) so glucose homeostasis is maintained. Thus, the normal system of glucose homeostasis is based on ss-cell adaptive mechanisms that entail molecular and signaling processes that are not dependent on sustained changes in glycemia. Surprisingly little is known about this fundamental feature of how ss-cells function. The overall goal of our studies is to identify the ss-cell biochemical, molecular and functional events that underlie this adaptation. Our laboratory has taken the approach of studying rodents with successful ss-cell adaptation to a lowered ss-cell mass or insulin resistance as defined by normoglycemia. This application continues our studies of the ss-cell adaptive mechanisms to a reduction in ss-cell mass as occurs in evolving type 1 diabetes, also likely type 2 diabetes, using the experimental model of 60% pancreatectomy (Px). We now propose to test a well-defined mechanistic schema based on our findings from the prior funding period, by performing Px studies in mice with genetically altered expression of key elements of the proposed regulatory pathway. Specifically, we propose an essential role for hyperexpression of ss-cell PPARg to upregulate trans- cription of key genes for ss-cell function and survival (pdx-1), the incretin system (GIP receptor), and mitochondrial fuel metabolism (pyruvate carboxylase). Also, we propose deactivation of the FoxO1 inhibitory upstream regulation of PPARg transcription is the mechanism for the PPARg hyperexpression. Finally, we pro- pose that disruption of this signaling system is responsible for features of the ss-cell dysfunction in animal and human type 2 diabetes. We will test these hypotheses in mice with genetically altered expression of key elements in the proposed signaling pathways - pancreas specific PPARg knockout, whole animal hetero- zygous FoxO1, and constitutively nuclear FoxO1 in ss-cells and liver - that undergo 60% Px or treatment with pharmacologic activators of the proposed signaling pathway. Parallel in vitro studies will be performed in mouse and human islets and INS-1 cells. A notable feature is the interdisciplinary nature of the studies because of the complimentary expertise of the principal investigator Jack Leahy (ss-cell biochemistry, physiology, in vivo animal models) with Tom Jetton (imaging techniques to study islet cell biology) and Mina Peshavaria (molecular and cellular biology of the ss- cell) at the University of Vermont.